General anesthetic modulation of memory through alpha5-GABA(A) receptors on Lamp5-expressing interneurons

Project Summary/Abstract
The long-term objective of the research is to understand the mechanism of general anesthesia, relating
specific molecular- and cellular-level targets to their behavioral-level consequences. This proposal focuses on
the role of hippocampal GABAA receptors in the suppression of learning and memory. Three specific aims test
the hypotheses that etomidate and other general anesthetics suppress memory by targeting 5-GABAARs on
Lamp5-expressing interneurons (Lamp5-INs), that they do so through an excitatory action on the axons of
Lamp5-INs, and that they enhance memory by targeting one of the classes of non-Cck-INs. Specific Aim 1)
Test the role of 5-GABAARs on Lamp5-INs in etomidate modulation of inhibitory neurotransmission and
memory, studying mice in which 5-GABAARs have been eliminated from Lamp5-expressing interneurons,
testing effects of etomidate on contextual conditioning, on place cell and spatial engram formation as neural
correlates of hippocampal memory, and on anesthetic-induced changes in neurotransmission. Specific Aim 2)
Identify the interneuron subtype(s) that counteract Cck-INs to enhance memory, studying mice in which
5-GABAARs have been eliminated using combinations of Cre-drivers. Specifc Aim 3) Test whether other
anesthetics suppress memory through 5-GABAARs on Lamp5-INs, studying effects of propofol,
midazolam, sevoflurane, and ketamine on contextual conditioning and place cell and spatial engram formation
in mice in which 5-GABAARs have been eliminated from Lamp5-expressing interneurons. Overall, the
experiments will further our understanding of the mechanisms by which anesthetics suppress learning. More
broadly, they will contribute to our basic understanding of how memory is supported and controlled by
interneurons. Given the essential role of interneurons in circuit function, the results will have widespread
application to learning deficits in Alzheimer’s disease and numerous other diseases associated with impairments
of learning and memory.

Public health relevance
Project Narrative We will investigate how etomidate and other general anesthetics suppress and enhance memory formation. The information we learn will also help us understand the neural systems that are in place to control learning and memory in the healthy brain, how these systems are altered in certain disease states, and how they might be manipulated to improve cognitive function.